New PET/CT System for Human and Non-human Primate Imaging

PROJECT SUMMARY
Weill Cornell Medical College of Cornell University (WCM) requests High-End Instrumentation Grant
Program support to purchase a new positron emission tomography/computed tomography (PET/CT)
system for imaging humans and non-human primates. Our PET/CT operations are a major component of
WCM strategic investment in crucial imaging infrastructure used to advance basic, translational and clinical
research, and provides vital tools for our large and growing pool of investigators who utilize PET/CT in their
projects. At this point, our existing PET/CT scanner is 12 years old and cannot handle the demand from
our large and growing pool of NIH funded investigators. In addition, we now require features such as a
long axial field-of-view that are not available on our current PET/CT configuration. WCM is a world
leader in biomedical research, and our PET/CT operations have leveraged the technical expertise of our
institution to provide support to 35 PET related research projects including 28 NIH supported grants. The
proposed whole-body PET/CT scanner is the Vision Quadra system offered by Siemens Healthineers. This
new instrument will provide us with state-of-the-art technology, including a 1 meter axial field of view and
greatly increased detection sensitivity that will facilitate innovative research projects using PET/CT over the
next two decades. Successful completion of this project will contribute significantly to our goal of understanding
and treating a wide range of diseases, including neurodegeneration, cancers, psychiatric disorders, genetic
disorders, inflammatory diseases, and vascular diseases. The PET/CT suite would be located at Weill Cornell
Medical College’s Citigroup Biomedical Imaging Center (CBIC), which is a dedicated, comprehensive, imaging
research and development facility located on the campus of the College. The CBIC operates as an imaging
research Core facility that serves over 100 investigators from 12 institutions in the greater New York area. The
proposed new scanner is critical to our mission of providing high-level, uninterrupted research support for
investigators funded by the National Institutes of Health and other sponsors. The proposed scanner will largely
replace our current Siemens Biograph mCT system, since its whole-body coverage will significantly advance
our research into questions related to the multi-organ nature of many diseases. The new scanner would be
used to address critical problems at the frontiers of neurology, including Alzheimer’s disease, Parkinson’s
disease, multiple sclerosis, stroke, and traumatic brain injury, as well as genetic medicine, including studies of
the biodistribution of viral vectors, and the development of precision medicine in oncology.

Public health relevance
PROJECT NARRATIVE Funding is requested for a new state-of-the-art positron emission tomography/computed tomography (PET/CT) system at Weill Cornell Medical College’s Citigroup Biomedical Imaging Center. The requested scanner will replace outdated equipment and offer state-of-the-art capabilities for imaging research studies targeting a wide range of human diseases. This new instrument is critical to support the recent rapid growth in the number of scientists at Weill Cornell who are developing innovative imaging biomarkers as well as novel PET technology to aid in the diagnosis, prognosis, and therapeutic monitoring of human disease.